BD FACSDiscover S8: A multi-laser spectral cell sorter with BD CellView Image Technology

Project Summary/ Abstract
The aim of the Robert H. Lurie Comprehensive Cancer Center Flow Cytometry Core Facility is to
provide analysis and cell sorting to enhance scientific interaction and productivity within Northwestern
University’s research community. This is accomplished by allowing access to quality controlled highly
specialized technology, education, and technical assistance in a cost-effective manner. All sorting
demands for the entire campus are accomplished on six BD instruments (four high-end and two mid-
level sorters) and one Miltenyi MACSQuant Tyto. Our high-end sorters are heavily utilized and
exceed over 4900 hours, even though our total practical capacity is 4572 hours. Additionally,
three of our high-end sorters are also nearing their end-of-life (over 10 years and showing
increased downtimes resulting from age and repairs. This, together with the increased user
demand, leads to scheduling wait times of 2-4 weeks. Since much of our user base utilizes human
patient and other time-sensitive specimens, which tend to come in at short notice, we are no longer
able to accommodate these sorting requests in a timely manner. Should a sorter be down due to major
repairs or must be decommissioned due to extensiveness of repairs; not having a replacement sorter
to provide uninterrupted service, further hinders investigators’ research. Additionally, with installation
of a 5-laser 50-parameter BD FACSymphony S6 cell sorter in 2021, many of the users have transitioned
or are in the process of transitioning to more complex 18-33 color assays for spectral based-cell sorting.
However, the current FACSAria’s lack the ability to translate these panels directly into cell sorting for
further downstream assays, thus limiting research. This proposal is for purchase of a 5-laser 78-
fluorescent detector system (86-parameters total) BD FACSDiscover S8 cell sorter with CellView Image
Technology, integrated in a biosafety cabinet. This is the first high-dimensional sorter combining
spectral flow cytometry with real-time spatial and morphological insights, thus empowering scientists to
address previously impossible-to-answer questions. The CellView Image Technology will further
enhance and allow for assays including sort QC, label-free sorting, fluorescent localization, cell-cycle
analysis and cell-cell interactions. The instrument, in addition to providing the acutely needed additional
capacity, will accommodate the high parameter cell sorting demands and allow for better detection and
efficient sorting of rarer events. The sorter will be permanently integrated in a Baker Class II Type A2
biosafety hood. This will provide state-of-the-art cell sorter instrumentation that can keep pace with the
technological advances and growing needs of future. This sorter will enable safe single cell high-
parameter image-capable spectral cell sorting of human and other animal specimen to meet the
increasingly complex needs of our user base and advancing research in a timely manner.

Public health relevance
Project Narrative Over the past five years, we have observed an over 300% increase in the number of hours of cell sorting since 2016 and now have reached maximum capacity on 3 high-end, end-of-life cell sorters. The proposed Special Order BD FACSDiscover S8 Spectral Cell Sorter with BD CellView Image Technology will accelerate the rate of scientific discovery by providing reliable capacity and cutting- edge capabilities based on principles of high dimension spectral flow and simultaneous sort-capable imaging that is central for primary human-based cell sorting and other fields alike. Together, this machine will meet the needs of the rapidly developing translational research initiatives at Northwestern University.